Magnetoencephalography based tracking of fetal neurodevelopment in diabetic pregnancies

Abstract
The prevalence of Type 1 Diabetes (T1D) and Type 2 Diabetes (T2D) is on the rise and represents a health
concern for women of childbearing age. Over an 8 year period, a major increase in the prevalence of births
complicated by pre-gestational diabetes increased by 50% .Pre-gestational diabetes is one of the most common
maternal risk factors for maternal, fetal, and infant complications. Preliminary evidence by our group evaluated
inflammatory biomarkers in pregnant subjects longitudinally during gestation. Several inflammatory cytokines
including C-reactive protein (CRP) were significantly elevated in T2D relative to non-diabetic controls, and this
effect was more evident in the third trimester. Thus, maternal inflammation later in pregnancy may represent an
important mechanistic link associated with health risks for mother an infant in diabetic pregnancy. Infants and
children from diabetic mothers are more likely to suffer neurological impairments compared to offspring of non-
diabetic mothers. Thus, we hypothesized that the increase in third trimester inflammation found in diabetic
pregnancy could adversely impact fetal brain development, a significant period of brain growth in humans. A
majority of the studies to date have linked poor infant outcome with various maternal risk factors. However, these
studies were limited in that the assessments did not occur in real time. The world’s first biomagnetic sensing
system at UAMS was built specifically to track and understand the process of fetal brain development. The SARA
(SQUID Array for Reproductive Assessment) system consists of 151 primary superconducting sensors which
detect biomagnetic fields generated in the body including fetal heart, and fetal brain. SARA is based on the non-
invasive magnetoencephalography (MEG) technique that permits the investigation of fetal parameters from early
gestation until delivery. We developed an optimized combination of recording parameters using auditory and
visual stimuli and spontaneous brain activity for a multimodal approach to understand fetal neurological
development trajectory. The overall goal is to correlate fetal and infant brain development with inflammatory
markers in mothers with pre-gestational T1D and T2D. We will obtain maternal blood samples for cytokine
assessment at their regularly scheduled third trimester SARA visit. We will also collect maternal and cord blood
samples at delivery. Aim 1: Implement an integrated multimodal approach to investigate fetal and neonatal brain
activity along with assessment of blood inflammatory biomarkers in pre-gestational diabetic mothers. Aim 2:
Track and quantify brain activity using MEG signals during fetal and neonatal stage of life. Aim 3: Correlate the
inflammatory biomarkers to fetal and neonatal brain activity.

Public health relevance
Relevance Documenting fetal and brain assessments and comparing them with maternal inflammatory biomarkers in diabetic pregnancy will provide novel insight into mechanisms reported previously in strictly observational studies of maternal inflammation and adverse infant outcome to identify targets for potential therapeutic options and interventional treatments in diabetic pregnancy.